mPFC Regulation of VTA Dopamine and GABA Neuronal Activity During Flexible Updating of Appetitive and Aversive Associations

Project Summary/Abstract
In order to efficiently traverse an environment, one must learn to distinguish among cues that predict
outcomes of different modalities, such as an appetitive reward or an aversive shock. In a dynamic environment
where cues predicting rewarding or aversive outcomes unexpectedly change, it is adaptive to flexibly update
behavioral responding while retaining the ability to recall previous associations. Impairments in the ability to
appropriately respond to cues according to the outcome are evident in a number of psychiatric disorders. The
overarching aim of my postdoctoral training is to better understand the neural circuitry responsible for updating
previously learned cue-outcome associations.
A large literature has implicated the ventral tegmental area (VTA) in the initial learning of appetitive and
aversive associations. Both dopamine and γ-aminobutyric acid (GABA) neurons in the VTA are involved
individually or cooperatively in different aspects of appetitive and aversive learning. After initial learning, I
hypothesize that flexible responding to changes in outcome contingencies is modulated by the medial
prefrontal cortex (mPFC) projections to the VTA in a valence-specific manner. To behaviorally quantify initial
learning as well as updating cue-outcome associations, I will use a flexible contingency learning (FCL) task in
which three distinct cues are paired with either an appetitive outcome (sugar pellet reward), an aversive
outcome (mild foot shock), or no outcome. After learning, the appetitive and aversive outcomes reverse such
that the cue previously paired with a shock will instead precede reward delivery and vice versa. I will be trained
in fiber photometry recordings from VTA dopamine and GABA neurons as well as chemogenetic manipulation
of the mPFC-VTA pathway to test whether the mPFC regulates flexible updating in a valence-specific manner.
Regardless of the outcome, the proposed work will increase our understanding of the flexible updating of
behavioral responding when outcome contingencies change.

Public health relevance
Project Narrative Expression of behavioral flexibility when cue-outcome associations change is adaptive for survival. This training proposal will use a rodent behavioral model to investigate the role of a cortico-subcortical circuit during the updating of previously learned cue-outcome associations.